Consortium Coordinating Center for Social, Behavioral, and Economic Research on Public Health Emergencies

Project Summary/Abstract Over the past 60 years, the Inter-university Consortium for Political and Social Research (ICPSR) has successfully coordinated the research needs for over 800 universities and research institutes. This work has led to the expanded use of secondary data, the development of innovative lines of research, and the training of multiple generations of scholars across the fields of social and behavioral sciences. The role of the social sciences in understanding major health challenges and disasters has expanded rapidly over the past several decades, and ICPSR in partnership with the Institute for Social Research (ISR) has played a key role in offering an infrastructure to support this work. New areas and new directions have emerged (e.g., population health, growth of longitudinal studies, and complex national population-based surveys). ICPSR has been able to bring together and share cutting-edge research emerging from cross disciplinary collaborations in a systematic manner using an open science model of information distribution. An ICPSR-led consortium model for social, behavioral, and economic (SBE) research will provide a nexus for communication, streamlining information-sharing across the behavioral and social science community, multiple NIH Centers, and to the public. This proposal creates a new independent Social, Behavioral, and Economic Research Consortium Coordinating Center (SBECCC) for research related to pandemics and other public health emergencies. To maximize the growth of cross-disciplinary research, its mission will also expand to promote collaborative work between the funded U01 projects, other NIH Research Centers, and a multidisciplinary research community each with different missions, cultures, and ethos. The SBECCC will involve experts from the Survey Research Center in ISR, the Program for Research on Black Americans in ISR, and the Center for Health and Research Transformation at the University of Michigan to develop the consortium, SBE research projects, and produce dissemination materials that aggregate and synthesize research findings emerging from NIH investments in research on public health emergencies.

Public health relevance
This proposal aims to launch a Consortium Coordinating Center to serve the goals of facilitating communication between Social, Behavioral, and Economic Research on public health emergencies, facilitating collaboration within and across the funded U01 projects, associated NIH Centers, and disseminating research advances, activities, and resources to a broad audience of stakeholders. Through these efforts, the Consortium Coordinating Center significantly magnifies the impact of SBE activities and findings.